The Unique Roles of Tumor-Specific Th9 Cells for Solid Tumor Eradication

Project Summary
Our early studies have characterized IL-9-producing CD4+ T helper (Th9) cells as an antitumor T cell subset.
Recently, we also revealed Th9 cells as a novel T cell paradigm for ACT – they are less exhausted, fully
cytolytic, and hyperproliferative; and efficiently kills targeted antigen-positive tumor cells. In the current project,
we will use tumor models that faithfully recapitulate the clinical scenario of ACT in solid tumors, to uncover
unique features of tumor-specific Th9 cells that enable them to efficiently eradicate advanced solid tumors. We
hypothesize that anti-solid tumor activity of Th9 cells are mainly attributed to both enhanced Th9 cell
penetration into stroma-rich solid tumors and restrain relapse caused by acquired resistance due to high
heterogeneity in tumor antigen expression. Aim 1 will determine the role of Pu.1-dependent MMP12 production
in Th9 cells for their efficient penetration into solid tumors to exert antitumor functions. Aim 2 will determine the
role of Th9 cells in promoting an eATP-enriched milieu to eradicate the TANTs in solid tumors and prevent
acquired resistance. Our proposed studies will identify tumor-specific Th9 cells as the first antitumor T cell
subset that are endowed with the capacity to eliminate solid tumors with the heterogeneity in tumor antigen
expression. This translationally relevant work holds promise to significantly advance the therapeutic index of
ACT in solid tumors and could then lay the foundation for future clinical trials.

Public health relevance
Project Narrative In this project we will determine the roles of specialized white blood cells, called tumor-specific interleukin 9- producing T cells, in promoting an immune response against solid tumors in mice and determine their potential for use in cancer adoptive cell immunotherapy. We hypothesize that transfer of these tumor-specific T cells will eradicate large established tumors and prevent recurrence in vivo in both mouse and human tumor models, due to their ability to 1) directly kill the tumor cells; 2) penetration into stroma-rich solid tumors, and 3) restrain relapse caused by acquired resistance due to high heterogeneity in tumor antigen expression.